Function and regulation of the essential RNA binding protein, DRBD18

ABSTRACT
The flagellated protozoan, Trypanosoma brucei, is a devastating human and veterinary parasite in sub-
Saharan Africa, and the causative agent of Human African Trypanosomiasis (HAT). HAT is fatal if untreated,
vaccination is not an option, and available drugs are toxic, difficult to administer, and expensive. In the search
for new treatments, understanding the basic biology of the parasite is a cornerstone on the path to discovery of
unique biological processes that could potentially serve as drug targets. Trypanosomes are exceptional in that
they perform gene regulation almost exclusively at posttranscriptional levels, through control of processes such
as mRNA stability and translational efficiency. This reliance on posttranscriptional regulation necessitates that
RNA binding proteins (RBPs) are the key effectors of trypanosome development, homeostasis, and virulence.
Our laboratory discovered DRBD18, an abundant RBP that is essential for the survival of both the human
bloodstream form (BF) and the insect vector procyclic form (PF) of T. brucei, and that is not conserved outside
the Order Kinetoplastida. DRBD18 depletion in the PF results in significant changes in the abundance of nearly
1000 mRNAs, many of the most highly regulated themselves encoding RBPs and protein kinases. Thus,
DRBD18 is positioned at the apex of numerous potential regulatory cascades. Proteomic data suggest that
DRBD18 functions in both nuclear mRNA export and translation initiation. Remarkably, the ability of DRBD18
to stabilize or destabilize mRNAs as well as both its protein and mRNA binding specificities are dramatically
regulated by arginine methylation, which acts as a molecular switch towards DRBD18 action. In the proposed
studies, we will elucidate DRBD18 functions and regulation by 1) identifying direct DRBD18 mRNA targets, 2)
mechanistically defining DRBD18 effector pathways, and 3) establishing the methylation-responsiveness of
DRBD18 interactions and DRBD18 functions. In Aim 1, we will use iCLIP to define on a genome-wide level the
sets of mRNAs that are directly bound by DRBD18 and to determine how these sets of bound mRNAs are
regulated upon DRBD18 methylation. In Aim 2, we will determine the roles of DRBD18 in nuclear mRNA export
and translation initiation, and test hypotheses regarding regulation of these functions by arginine methylation.
In Aim 3, we will study combinatorial RBP interactions and test the hypothesis that methylation-sensitive
interactions between DRBD18 and other RBPs regulate the specificity of DRBD18 mRNA targeting. Our
studies will define distinct cis-trans modules that mediate methylation-sensitive DRDB18 functions. Using
combined genetic, genomic, and biochemical approaches, the proposed studies will provide fundamental
insights into specific gene regulatory events in T. brucei, and uncover regulatory mechanisms with wide-
ranging applicability in trypanosomes. They also have the potential to broaden our understanding of RNA
biology and its regulation by arginine methylation in higher organisms.

Public health relevance
PROJECT NARRATIVE The goal of this this application is to determine the functions of the trypanosome RNA binding protein (RBP), DRBD18, and to elucidate the mechanisms by which arginine methylation regulates DRBD18 action. DRBD18 is essential in both human and insect stage T. brucei, abundant, and multi- functional, and its depletion leads to significant changes in the abundance of almost 1000 mRNAs. The proposed studies will significantly increase our mechanistic understanding of this essential protein a medically and economically important parasite.